Defining the Roles of Bone Marrow Adipocytes and FABP4/5 Signaling in Multiple Myeloma Drug Resistance

ABSTRACT – MERIT EXTENSION
The overall goal of this MERIT Extension research project is to support the original goals of our parent grant
and build logically on our findings, while staying within the scope of the parent grant. My parental R37 focuses
on examining how fatty acid-binding proteins (FABPs) impact multiple myeloma (MM), an incurable blood
cancer that results from mutations that accumulate in the plasma cell. Myeloma cells grow in the rich soil of the
bone marrow (BM), first very slowly, and then more quickly and aggressively, causing degradation of the bone
and development of drug resistant clones. Although therapies exist, novel approaches to myeloma therapy are
needed. Our prior work suggested that myeloma cells can become drug resistant and proliferate faster through
support from proteins called fatty acid-binding proteins 4 and 5 (FABP4 and FABP5). In Specific Aim 1 of our
parent award, we are analyzing how BM adipocytes and the FABPs contribute to myeloma by using novel,
three-dimensional (3D), tissue engineered cancer models as well as FABP inhibition methods. In Specific Aim
2, we use mouse models to study the roles of the FABP members in MM, as well as the roles of BM
adipocytes. The long-term goal of our work is to understand molecules and mechanisms driving MM growth;
this Extension and Parent project specifically will identify new mediators driving MM and propose paradigm-
shifting concepts to guide the development of new anti-MM therapies. The proposed studies in this Extension
build on our prior and ongoing work in the Parent award, and add complementary data and translational
significance to the findings. Both Extension Aims will be used to identify translationally significant effects and
mechanisms of FABP actions on tumor cells and on the tumor immune microenvironment. Our Extension
Specific Aim 1 is to Create FABP5 and FABP6 knockdown (KD) MM cells and phenotype these cells in
vitro & in vivo. Our Extension Specific 2 is to Investigate the effects of obesity on MM growth and drug
resistance, and the roles of FABPs in this process using FABP inhibitors and Fabp4/5dKO in vivo
models. This Extension will explore the roles of the FABPs in MM cell growth, survival, and drug resistance in
vitro and in vivo using oral administration of the FABP inhibitor BMS309403 and using a FABP4/5dKO (double
homozygous knockout) mouse model. Analyses of tumor and non-tumor BM microenvironment cells, as well
as mouse serum, blood, and other tissues are intended to illuminate the actions of FABP inhibition not only on
tumor cells, but also on surrounding cells and the mouse overall. This work in thoroughly understanding the
potential roles and mechanisms of action for the FABPs in MM is essential in moving towards clinical use.

Public health relevance
NARRATIVE The overall goal of this application is to change how multiple myeloma, an incurable blood cancer, is understood and treated. We will discover new forms of cancer drug resistance that are driven by fat cell-derived factors. Thus, we will expose new interventions to overcome drug resistance to improve survival and quality of life for myeloma patients and patients with other cancers that grow in the bone.